PLANNING AND EVALUATION

PROJECT SUMMARY (See instructions): The 2007 NCI Review of the UCCCC CCSG was a catalyst for our own institutional in-depth review, followed by a multi-faceted strategic planning process, which has fundamentally and substantially enhanced the UCCCC structure and strengthened Its position within the University. Our strategic planning and evaluation relies on formal internal and external advisory structures and groups. Internal advisory groups include: the Executive Committee (EC), the Cancer Advisory Committee (CAC), the Internal Advisory Committee (lAC), Program Leaders meetings, and the Core Development Working Group (CDWG). In addition, UCCCC senior leaders play a key role in the Dean's Clinical Cancer Program Strategic Growth Committee. External advisory mechanisms include annual External Advisory Committee (EAC) meetings and smaller targeted

Public health relevance
RELEVANCE (See instructions): Planning and evaluation activities are critical to the success of the UCCCC. The mechanisms described above provide the structure within which we review our Programs and Cores to ensure state-of-the art research, enhance intra- and inter-programmatic collaborations, and identify opportunities for continued growth and development. These activities also serve as an important opportunity to engage the Institutional leadership in both creating an institutionally-based cancer-related vision and, supporting the UCCCC In its leadership role to realize this vision.